Special Projects Method Development and Method Validation

Missouri Department of Health and Senior Services State Public Health Laboratory Project Abstract for FOA PAR-20-105 Laboratory Flexible Funding Model Discipline D (Special Projects): Track 3 Method Development and Method Validation Purpose: The Missouri Department of Health and Senior Services (DHSS) State Public Health Laboratory (MSPHL) seeks FDA cooperative agreement funding opportunity to enhance food testing capabilities through the multi-laboratory validation of QPCR screening method for Salmonella in Foods. The goals and outcomes of this cooperative agreement include the following: 1. The MSPHL will participate in FDA led multi-laboratory validation. 2. The validation will follow FDA guidelines for Validation of Analytical Methods. 3. This validation will enhance MSPHL’s capability of screening for Salmonella in foods. Page 1 of 1